Rapid measurement of novel harm reduction housing on HIV risk, treatment uptake, drug use and supply

The COVID-19 pandemic has strained an ongoing housing crisis across cities and towns, leaving unprecedented
numbers of people homeless and creating poor health conditions in precarious, concentrated homeless
encampments. In Boston, Massachusetts, an October 2021 public health emergency declaration preceded a
January 2022 massive relocation campaign that moved over 200 people from a large street encampment into 5
novel “harm reduction housing” (HRH) programs. The area is known for its proximity to area hospitals, its
open-air drug market, and violence related to drugs and crime. These programs provide housing units with
access to harm reduction supplies like sterile syringes and other safer use materials, naloxone, and low-barrier
medication treatment, and staff provide these services according to policies that champion the principles of
“meeting people where they are”. But the HRH sites differ in ways that may affect resident outcomes, and
uptake of services vary. Data suggest that housing interventions may tragically increase isolation and thus
overdose risk; others claim lives will be saved and life-saving treatments will start because of their improved
access at the HRH sites. An initial case-crossover analysis of those recently relocated echoed a mixture of
positive and negative effects. Lacking clear-cut, scientifically rigorous processes that consider both intended
and unintended consequences of these actions, we propose a rapid, mixed methods study to efficiently examine
the immediate effects of the relocation efforts and the longer-term impacts of living in the novel HRH.
Specifically, this time-sensitive study will collect survey, interview, and drug supply data from the community
of people who are homeless and use drugs in the concentrated area of Boston who have been affected by these
recent actions. The study will help to determine short and long-term impacts of: a) rapid relocation and how
residents successfully navigated it; and b) co-provision of harm reduction services and housing on individual-
level behaviors and local drug supply outcomes. Specific aims are to: Aim 1) Develop a measure of harm
reduction services and policies to inventory their provision and use in HRH sites for studying continuity,
uptake, and evolution of care. Aim 2) Enroll an observational cohort following 100 HRH residents for 12
months to catalogue relocation effects and understand how harm reduction services use changes drug use, HIV
and drug risk behaviors, treatment uptake, and the local drug supply. Data specific to new HRH resident cohort
members will augment our prior case-crossover analysis of relocation impacts. Aim 3) Conduct repeat,
longitudinal one-on-one interviews with 25 cohort members to gain greater insight into the nuances of
relocation and HRH residence, including health and safety impacts, changes in collective efficacy, and gender
considerations. Findings will contribute to harm reduction science and will be directly relevant to jurisdictions
considering HRH, adapting housing contracts to incorporate harm reduction services, and planning public
health-directed mitigation plans for housing relocations or disaster responses.

Public health relevance
PROJECT NARRATIVE This study will collect survey, interview, and drug supply data from the community of people who are homeless and who use drugs in the area of Boston known as “Mass and Cass” who have been affected by a recent large- scale street encampment relocation and provided housing equipped with harm reduction services. The study will learn from residents about the impacts of the public health-led relocation and how co-provision of harm reduction services onsite within a housing environment changes drug use, HIV risk behaviors, treatment uptake and the local drug supply.